Dose-Dependent Effects of Hormone on the Activity of Estrogen Receptor Enhancers and Target Genes

Project Summary/Abstract
Cellular signaling by estrogens plays a critical role in the development and physiology of a wide variety of tissues,
including the reproductive organs, mammary glands, bone, heart, vasculature, adipose, liver, and central nervous
system, as well as diseases of the same tissues. Within an individual, estrogen levels may fluctuate dramatically
and acutely across multiple time scales: hours, days, months, years, and decades. The circulating levels of 17b-
estradiol (E2), the predominant naturally-occurring estrogen, fluctuate dramatically in women from lows of ~70
pM to highs of ~1.8 nM in the non-pregnant state. In contrast, most molecular, cellular, and genomic studies use
saturating supraphysiological levels of E2 (e.g., 10-100 nM). Although the importance of dose, and the frequency
and duration of administration, have long been recognized as important aspects of the therapeutic use of steroid
hormones, the effects of physiological doses of E2 on molecular, cellular, and genomic endpoints have not been
well characterized. Our proposed studies will address these key gaps in knowledge.
The molecular actions of E2 are mediated through estrogen receptor proteins (e.g., ERa), which function
primarily as ligand-regulated transcription factors that drive cell type-specific patterns of gene expression by
promoting the coordinated assembly of transcriptional enhancers at ERa binding sites. There is a growing
interest in the mechanisms and functions of signal-regulated enhancers, but many questions remain. For
example, we do not have a detailed understanding of (1) how different doses of E2 may differentially regulate
the assembly and function of ERa enhancers across the genome and (2) how different dose sensitivities of ERa
enhancers may lead drive distinct biological outcomes in different estrogen-responsive biological systems.
The overarching goal of these studies is to gain a better understand the molecular mechanisms by
which E2 controls ERa enhancers to regulate gene expression and downstream biological outcomes. Our broad
hypothesis, which is supported by considerable preliminary data, is that different ERa enhancers and target
genes exhibit different sensitivities to the dose of E2, specifying different classes of enhancers with different
mechanisms of action. We will test this hypothesis in two ERa-positive cell types (i.e., human breast cancer
cells and primary mouse myometrial cells) using an integrated set of experimental approaches. Our specific
aims are to: (1) Characterize dose-effects of E2 on molecular and genomic endpoints of estrogen signaling (Aim
1); (2) Determine the molecular mechanisms by which different doses of E2 promote enhancer activity (Aim 2);
and (3) Explore genetic determinants underlying dose-effects of E2 on biological endpoints (Aim 3).
Our studies on the molecular mechanisms and functions of ERa enhancers seek to challenge and expand
current approaches and biological models for studying the mechanisms of steroid hormone signaling. These
studies will yield new knowledge about the molecular mechanisms of E2 signaling; a diverse collection of
genomic data; and new concepts about E2 signaling that may suggest new ways to target ERa therapeutically.

Public health relevance
Project Narrative/Relevance Estrogens play critical roles in the normal development and function of reproductive organs, mammary glands, bone, heart, vasculature, adipose, and the central nervous system, as well as diseases of the same tissues. Although the importance of hormone dose, and the frequency and duration of administration, have long been recognized as important aspects of the therapeutic use of steroid hormones, the effects of physiological doses of estrogens on molecular, cellular, and genomic endpoints have not been well characterized. Increased understanding of the molecular mechanisms of estrogen signaling over a wide range of hormones doses will aid in finding better ways to prevent, diagnose, and treat estrogen-related diseases, as well as suggest new ways to study the biology of estrogens in health and disease.